Training Fellowship

This is a shared training slot between several groups with similar sc ientific interests. The goal of the training slot is to allow flexibility in bringing in high level trainees at the time when they are available rather than at the time an opening in one of the PI budgets exist. It is a way to pool and share resources. The prpograms are all focused on identifation of the the molecular mechaisms underlying cancer initiation, progression and metastasis. Sometimes the slots are used to host trainees with connections to two or more of the labs.